Circulating tumor cell profiling for genomic contributors to racial disparity in metastatic prostate cancer

PROJECT SUMMARY/ABSTRACT
In the United States, prostate cancer is the most prevalent malignancy, with disproportionately higher incidence
and mortality rates among black men than their white counterparts. Black-white mortality disparities have been
examined with differences in treatment based on socioeconomic factors implicated. Apart from these
contributors, the effect of molecular and genetic factors on racial disparity is evident. Compared to earlier studies
focusing on heritable mutations and single-nucleotide polymorphisms, more recently, tissue-based genomic
analyses enabled by next-generation sequencing technologies have emerged to investigate race-specific
somatic alterations and their clinical implications, and have already generated promising findings. However,
tissue-based genomic analysis is extremely challenging in metastatic prostate cancer because, as a bone-
predominant metastatic disease, tissue samples are not always obtainable. Analyses based on circulation tumor
cells (CTCs), an emerging liquid biopsy approach, can provide global snapshots of primary and metastatic
tumors, and provide information on spatial and temporal heterogeneity on a scale that cannot easily be achieved
through analyses of tissue biopsy samples. With recent advances in single-cell technologies, analyses of CTCs
at single-cell resolution offer a noninvasive approach to characterize and monitor dynamic changes of cancers
from a multidimensional perspective. Nonetheless, studies on single-cell CTC analysis have rarely been
reported, partly due to the considerable technology challenges. Moreover, there is no study so far to examine
the mutational landscape of CTCs in the context of racial survival disparity. Recently, we have established a
comprehensive pipeline on the enrichment, enumeration, isolation, whole genome amplification, sequencing,
and data analysis of single CTCs. Based on this pipeline, we were recently awarded an NCI R01 project to
develop a large prospective prostate cancer patient cohort to determine mutational landscapes of single CTCs
with treatment response and disease progression in metastatic prostate cancer. Intriguingly, our pilot whole-
exome sequencing analysis of single CTCs showed a distinct mutational signature between black and white
patients with metastatic castration-resistant prostate cancer (mCRPC). Building upon these research strengths,
available resources, and preliminary data, we will conduct whole-exome sequencing of CTCs from paired black
and white patients to identify race-specific mutational signatures and evaluate their associations with racial
survival disparity in mCRPC. By applying the cutting-edge single-cell sequencing technology in a large ongoing
multi-ethnic cohort, this proposed study has the promise to identify novel genomic biomarkers that are associated
with racial survival disparity in mCRPC, which may assist in prognosis stratification, precision medicine, and
optimal management of prostate cancer patients, including racial minorities who are underrepresented in
previous molecular profiling studies.

Public health relevance
PROJECT NARRATIVE Tissue-based genomic analyses enabled by next-generation sequencing technologies have emerged to investigate race-specific somatic alterations and their clinical implications; however, tissue-based analyses are extremely challenging in metastatic prostate cancer because, as a bone-predominant metastatic disease, tissue samples are not always obtainable. In this proposed study, we aim to identify race-specific somatic mutations that are associated with survival disparity between black and white patients with metastatic prostate cancer, using a liquid biopsy approach based on circulation tumor cell sequencing to characterize and monitor tumor dynamics. The identified race-specific prognosis-relevant mutational signatures may assist in prognosis stratification, precision medicine, and optimal management of prostate cancer patients, including racial minorities who are underrepresented in previous molecular profiling studies.